Mississippi State Department of Health , MFRPS, and RRT Flexible Funding Model Maintenance Grant Application

Flexible Funding Model-Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (U18) / Rapid Response Team
Maintenance Funding Option (Track 2)
Summary/Abstract
Introduction
The Mississippi State Department of Health Division of Food Protection (MSDH FP) is
applying for funding under the cooperative agreement with the Food and Drug
Administration, Funding Opportunity Announcement (FOA) Number RFA-FD-18-001,
Flexible funding Model-Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Program (U118) / Rapid Response Team maintenance
funding option.
The MSDH FP meets the below eligibility requirements outlined in the FOA.
Discussion
Prior to receiving the Manufactured Food Regulatory Program Standards (MFRPS)
/Rapid Response Team (RRT) grant funds, the MSDH FP was unable to execute the
MFRPS/RRT programs. The MFRPS cooperative agreement allowed the MSDH FP to
hire key personnel to move the manufactured food program forward to implement
required elements of the MFRPS. Furthermore, the RRT funds enabled the MSDH FP
to assemble and train essential personnel for food-related incidents.
The Flexible Funding Model-Infrastructure Maintenance for State Manufactured Food
Regulatory Programs/Rapid Response Team grant will provide the MSDH FP with the
necessary funding to provide staff with the support needed to maintain the requirements
set forth in the MFRPS, maintain a trained RRT staff, and maintain necessary
equipment/supplies in the event of a food-related incident.
Results
Through previous MFRPS/RRT funding, the MSDH FP program has investigated,
developed, written and implemented procedures for the regulatory program for MSDH
MFRPS, Standards 1-10 and for rapid response to food emergencies.
The Flexible Funding Model-Infrastructure Maintenance for State Manufactured Food
Regulatory Programs grant will provide the MSDH FP Staff the resources needed to
continue maintenance and improvements to the MFRPS, Standards 1-10 and to the
best practices of the RRT.

Public health relevance
Project Narrative The mission of the Mississippi State Department of Health is to promote and protect the health of the citizens of Mississippi. The funds provided through the Food and Drug Administration (FDA), RFA-FD-18-001, Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs - Rapid Response Team maintenance will promote the maintenance of a high quality regulatory program while enhancing the program’s ability to protect public health.